Cytoskeletal regulation and Yap/Taz activity in differentiating retinal neurons

PROJECT SUMMARY / ABSTRACT The human retina does not regenerate after injury. This proposal examines retinal development to better understand the molecular mechanisms that could be used to initiate regeneration. Developing neurons must precisely regulate cytoskeletal dynamics to establish their unique morphology that is required for proper function. It is not well understood how cytoskeletal dynamics change across development and after injury in vivo. Yes Associated Protein (YAP) and Tafazzin (TAZ) are functionally similar proteins that are critical for maintaining the progenitor state through transcriptional regulation. Mutations to YAP/TAZ result in retinal lamination defects through an unknown mechanism. Additionally, unlike other retinal neurons, retinal ganglion cells continue to express YAP/TAZ after development. Intriguingly, cytoskeletal tension can inhibit YAP/TAZ activity and YAP/TAZ can regulate cytoskeletal dynamics. This creates an unusual molecular feedback loop between structural proteins and transcriptional regulators. The overall goal of this proposal is to understand the molecular mechanisms by which the cytoskeleton and YAP/TAZ coordinate retinal development, and the role they play in retinal regeneration. The central hypothesis is that cytoskeletal rearrangements required for retinal differentiation downregulate YAP/TAZ activity and thus drive cells out of the progenitor state. With the knowledge gained from these studies, the ultimate goal is to reverse engineer this process in adult cells, so we can then drive cells to a state of enhanced regenerative potential. To this end I will use a combination of innovative in vivo imaging techniques, genetic manipulations, and regeneration assays to better understand the molecular mechanisms by which the cytoskeleton and YAP/TAZ orchestrate retinal development and regeneration. The initial experiments in this proposal will focus on developing tools and techniques in zebrafish to investigate the cytoskeleton in order to test the overall hypothesis. Mastery of the zebrafish model system is a key element of the training potential of the K99 phase, and will complement my previous work examining retinal development in mice. Having technical expertise in both mouse and zebrafish will enable me to answer the most critical questions by having experimental access across retinal development, and a wide range of molecular and genetic tools. Taken together this training plan will empower me to develop an independent line of research that can significantly contribute to the development of regenerative therapies for the retina, and ultimately prevent vision loss.

Public health relevance
PROJECT NARRATIVE During development neurons go through a series of highly regulated molecular changes. This proposal will provide a better understanding of key molecules involved in this transition. Furthermore, it will test if regulation of these molecules can be used to promote regeneration of the retina after injury.